Columbia University Patient Safety and Health Services Research Training

This application proposes a new health services research training program with an emphasis on patient safety
in the hospital setting, which aligns with the AHRQ mission to provide evidence that improves the quality,
safety, and effectiveness of healthcare. The postdoctoral training program leverages the numerous resources
available at Columbia University, including the Mailman School of Public Health and the Irving Center for
Clinical and Translational Research (CTSA), as well as its affiliation with NewYork-Presbyterian/Columbia
University Medical Center. The purpose of the training program is to provide clinician-researchers with the
foundation and skills to become independent investigators in patient safety and health services research. The
program offers a unique combination of formal research education, mentored research projects, and exposure
to patient safety operations at a large academic medical center. Trainees will have the opportunity to work with
a diverse and accomplished group of Columbia faculty with a proven track record of grant funding,
interdisciplinary research collaboration, publication, and mentorship. Our Faculty Mentors represent a broad
range of clinical and academic disciplines including General Medicine, Pediatrics, Behavioral Cardiology,
Infectious Diseases, Psychiatry, Neurosurgery, Pathology, Biomedical Informatics, Nursing, Epidemiology, and
Health Policy. Faculty Mentors have expertise and active research support in AHRQ-related focus areas
including medical errors, medication safety, healthcare-associated infections, health informatics, quality
measurement and outcomes, cost and cost-effectiveness, chronic disease epidemiology, and health
disparities. This 2-year training program consists of four core training components: 1) Formal Research
Education; 2) Mentored Research Projects; 3) Patient Safety Immersion; and 4) Bi-Weekly Research
Seminars. All Trainees will earn a Master’s degree in Epidemiology or Patient Oriented Research from the
Mailman School of Public Health. In addition, a distinctive core component of the program is the Patient Safety
Immersion, consisting of a patient safety curriculum leading to the Certified Professional in Patient Safety
(CPPS) credential and a Trainee-developed research project based on real-world patient safety hazards.
Trainees will participate in Patient Safety operations at Columbia University Medical Center, including
reviewing adverse event reports and attending root cause analyses. A total of 11 Trainees will be admitted to
the program, all with a hospitalist career trajectory and a strong interest in patient safety and health services
research. Candidates will be recruited from Columbia’s top-ranked clinical training programs and through a
wide range of national recruitment strategies, with a particular focus on recruiting underrepresented groups.
The program will be centered in the Department of Medicine/Division of General Medicine, which houses the
Section of Hospital Medicine and a well-established Primary Care Research Fellowship along with existing
infrastructure to support training activities.

Public health relevance
Despite a heightened focus on patient safety over nearly the past two decades, preventable harms remain excessively high with implications for mortality, morbidity, and quality of life. This application proposes an innovative health services research training program with an emphasis on patient safety in the hospital setting. Our interdisciplinary postdoctoral training program will prepare the next generation of diverse clinician-researchers to generate evidence to improve patient safety, health outcomes, and health services.